Structural Investigation of the Central Components of the CD4+ T Cell Immunological Synapse

Project Summary
After nearly four decades since the first crystal structure of a human MHC was published, it is still
unclear how exactly T cells engage and become activated by peptide-MHC (pMHC) presented on host
cells. T cells are a cornerstone of the immune system, and the interface between T cells and host cells
consists of an ensemble of adhesion and signaling proteins known as the “immunological synapse.”
Central to this interface are pMHC and its binding partners—the T cell receptor (TCR)-CD3 complex
and coreceptor CD4 or CD8. The coreceptors can greatly amplify TCR binding and activation, and a
variety of mechanisms such as cooperativity, allostery, and oligomerization have been proposed.
Efforts to uncover this mystery through structural studies have resulted in atomic-resolution structures
of the individual proteins, allowing for theoretical structural models of pMHCII engaging TCR-CD3 and
CD4. However, the theoretical models have failed to explain how CD4 contributes to enhanced TCR
binding and signal transduction; therefore, experimentally determined structures of immunological
synapse are needed to shed light on this critical component of the immune system. In this proposal,
established methods, as well as new developments in engineering enveloped virus-like particles
(eVLPs), will be leveraged to determine novel experimental structures of the central components of the
immunological synapse.
The hypothesis is that the simultaneous binding of full-length TCR-CD3 and CD4 to pMHCII induces
biologically relevant structural changes that are not apparent in the current model obtained by
superimposing the protein complexes. In order to address this gap, in Aim (1) we will use cryo-electron
microscopy (cryo-EM) to determine the structure of pMHCII engaged with full-length TCR-CD3 and
CD4. While detergents are necessary to stabilize membrane proteins for cryo-EM, it would be beneficial
to visualize and compare the structures in a more native environment. Therefore, Aim (2) will use cryo-
EM and cryo-electron tomography (cryo-ET) to determine the structure of membrane-anchored pMHCII
engaged to TCR-CD3 and CD4 using enveloped virus-like particles (eVLPs). An endosomal sorting
complex required for transport (ESCRT) and ALG-2-interacting protein X (ALIX)- binding region (EABR)
motif will be appended to the intracellular tail of each protein, prompting the self-assembly and budding
of eVLPs containing pMHCII and separately eVLPs containing TCR-CD3 and CD4. Once initial
structures are obtained for each aim, CD4 variants that affect binding affinity or kinase Lck recruitment
will be introduced and structurally investigated. These data will reveal how T cells engage pMHCII and
will inform future strategies of modulating T cell activation for targeted disease treatment.

Public health relevance
Project Narrative T cells are fundamental to a healthy immune system. T cells become activated when T cell receptor and coreceptors bind to peptide-MHC, but exactly how they interact remains unknown. This project will visualize the T cell receptor, CD4 coreceptor, and peptide-MHC bound together in molecular detail and will provide new insights into understanding and modulating the immune system.